Administrative Core

ABSTRACT
Administrative Core
The Administrative Core supports the overall management of the P30 Grant. This Core is directed by the P30
Grant PI and includes the Executive Committee (comprised of the PI and Core Directors), the Core Managers,
the Advisory Committee, and administrative staff. The Executive Committee oversees the day-to-day
operations of the three grant resource Cores, which are run by highly experienced Core Managers. Each of the
Core Directors meets with the Core Manager(s) under his/her supervision at least once a week or on as
needed basis, if any issues arise, to quickly resolve these issues. In addition, Core Managers meet quarterly
with the P30 grant PI and administrative staff to discuss module usage and budget, equipment maintenance,
repair, and service contracts as well as any other activities related to the operations of the Cores. Also, there is
once a year a meeting of the P30 grant PI, Executive Committee, and Advisory Committee to evaluate the P30
grant services in terms of their effectiveness and fair use of the P30 grant resources as well as to make
strategic decisions pertaining to the P30 grant operations such as introduction of a new Core or Core service,
termination of an existing Core, major equipment purchase, and investment in new technologies. Finally, the
Executive Committee receives a direct feedback from the Core users during regular meetings with the Visual
Sciences Research Center PIs.